Comparative Biomedical Sciences Training Program

Summary: Veterinarians are at the forefront of the ‘ONE HEALTH’ strategic framework, which facilitates
collaborations among human medicine, veterinary medicine and ecosystem health that are of worldwide
benefit. The vital importance of veterinarians at the human-animal interface cannot be overstated, as
graphically illustrated by the tragic repercussions of the ongoing COVID-19 pandemic, and that 6 of 10 human
infectious diseases are zoonotic in nature. Reports from the National Academy of Sciences and the strategic
plan of the NIH Office of Infrastructure Programs (ORIP) emphasized the national need for veterinarians
trained in biomedical research to effectively deal with effects of climate change on animals and public health,
thwart the emergence of zoonotic diseases, and promote human and animal health.
We will address the national need for veterinary biomedical scientists through these specific aims:
Aim 1: Develop the next generation of independent veterinary medical researchers equipped with skill sets in
innovative and critical thinking, problem solving, robust experimental methodologies and rigorous data
interpretation.
Aim 2: Continually innovate professional development opportunities for veterinary medical scientists in
grantsmanship, science communication, team science, evidence-based mentor and mentee practices, and
forward-thinking leadership.
The School of Veterinary Medicine (SVM) and the University of Wisconsin-Madison offer an exceptional
research training environment and are ideally positioned to provide outstanding training to graduate
veterinarians in cutting-edge biomedical research. The excellent research training offered by this program is
highlighted by the (1) broad multidisciplinary portfolio of an outstanding group of trainers with a history of
sustained funding, productivity and commitment to graduate training; (2) nationally ranked multidisciplinary
research training program (Comparative Biomedical Sciences PhD program) with major strengths in infectious
disease and immunology, physiologic basis of health and disease, and developmental biology/regenerative
medicine; (3) proven ability to recruit and train a diverse group of outstanding veterinarians in biomedical
research; (4) strong research ethics and professional skills course and access to an array of
career/professional development programs; (5) commitment to minority student recruitment; and (6) strong
institutional and administrative support from the SVM and campus. We request funds to support four
postdoctoral DVM trainees per year to pursue PhD training in a 5-year period. The overall goal is to train
veterinary biomedical scientists in hypothesis-driven science who can assume leadership roles in biomedical
research, academic instruction, industry innovations, and government service in the 21st century.

Public health relevance
Narrative Veterinarians play a key role in biomedical research that includes studies of animal diseases, diseases shared by humans and animals, and spontaneously occurring or experimental animal models of human disease. This proposal will address the critical need for veterinarians trained in biomedical research by supporting the research training of four outstanding veterinarians (per year) by a team of 33 well-funded faculty with strong research training records at a campus with a superb training environment, exceptional resources, and a historical commitment to graduate student research training.